Quantitative Analysis

ABSTRACT – Core D
Core D will provide computational modeling and statistical analysis tools and services to investigators in the
CTMR. By combining approaches from biology, engineering and computing, the challenge is to transform the
field of muscle and movement sciences by focusing on a new understanding of multi-scale muscle biophysics
– from molecules to movement. In doing so, the unifying theory explaining how muscle develops, functions
and has dysfunction with disease and impacts other physiological systems will be developed. The core will
provide invaluable mulit-scale computational tools and visualization software to be used in multi-scale research
on metabolism (energy supply) and mechanical (energy demand/use), how these changes in developing
muscle and how they are altered in skeletal muscle disease. In doing so, the core will develop models that are
informative and provide predictive power that can guide experimental design and suggest targets for
development of novel therapeutic approaches to treat disease. The models and analytical tools developed in
this core will accelerate the pace of translational muscle research.